FLUORESCENT DRUG: MONITOR UPTAKE, RETENTION, SUBCELLULAR LOCALIZATION &LIFETIME

The uptake and binding of ellipticine was determined in viable human promyelocytic (HL-60) cells co-stained with Hoechst 33342 using a two-laser excitation flow cytometry system. Phase-sensitive FCM methods were used to measure the fluorescence lifetime of ellipticine bound within viable HL-60 cells. Ellipticine fluorescence lifetime was altered in both a time and dose dependent manner, demonstrating the disproportionate binding of ellipticine to DNA, to other cellular constituents. This study showed the utility of measuring the uptake and binding of chemotherapeutic agents in viable cell populations, and demonstrates the usefulness of fluorescence lifetime measurements. Further development of phase-sensitive flow cytometry will provide for resolution and quantitation of drugs, including adriamycin and other fluorescent drugs, to different sub-cellular components which cannot be resolved by conventional methods.